I/O Tags: Genetically Encoded Tags for Trans-Neuronal Control Across Specific Synapse Classes

PROJECT SUMMARY
The ground-truth definition, experimental control, and therapeutic treatment of neuronal circuits requires
technologies that perform well in vivo. Powerful tools that control and report signal transduction, neuronal activity,
and gene expression continue to emerge, but the field lacks robust technologies to deliver those tools throughout
long-distance neuronal circuits in the mammalian brain. The state-of-the-art relies on viruses that spread from
neurons to their retrograde (e.g. rabies) or anterograde (e.g. HSV1) partners. However, these viruses are
pathogens that can exhibit neurotoxicity and spread non-specifically, infecting any type of pre- or postsynaptic
neurons. This is problematic because the types of synaptic inputs to, and targets of, a given class of neuron are
diverse. Consequently, the unmet need for precision trans-neuronal delivery methods severely constrains
analyses of how interaction between different cell types influences brain function. While deliberate experimental
designs can enable the evaluation of specific types of inputs or outputs in some model systems (e.g., in mice,
zebrafish, or fruit fly), these designs rely on genetic modifications to the organism that grant access to unique
cell types. There is no such method for robust access from neurons to specific types of their inputs and outputs
in “higher” organisms. To address this gap, we propose a transformative project to develop tools that will go from
a given neuron starter population to different user-selectable types of its synaptically-connected cells, without
the need for replicative neurotropic viruses.
Our central goal is to create proteins that achieve targeted trans-neuronal delivery. Our novel strategy is to
encode the specificity for distinct types of connected neurons directly into designer proteins, I/O Tags. The I/O
Tags will function as fusions: when appended to other proteins, the latter will be ferried into selectable classes
of pre- or post-synaptic targets. The Tags will be comprised of combinations of motifs that, in concert, target
payloads to synapses, enable release, achieve entry into the preferred type cells, and execute a desired action.
We will screen deep libraries of Tag permutations in vivo by utilizing the mouse cerebellar cortex as a model
circuit to screen and validate I/O Tags. The investigators will leverage their areas of expertise to assay I/O Tags’
delivery from Purkinje cells into their synaptic partners, ensuring biological compatibility through microscopy,
electrophysiology, and behavior. With safety and utility demonstrated in mice, we will validate I/O Tags in ferrets,
tree shrews, and macaques. If successful, the outcome of this high-risk proposal will be transformative
technologies for trans-synaptic anterograde and retrograde delivery of biological agents. Our Tags will thus
seamlessly augment and catalyze existing approaches by enabling the targeted delivery of a diverse array of
existing tools, agnostic to the vector or species utilized. If successful, our project will fundamentally change the
state-of-the-art to enable targeted cell-type and circuit-specific experimentation and therapy evaluation.

Public health relevance
PROJECT NARRATIVE To understand memory, cognition, behavior, mood, and related disorders, there is a need to map and manipulate neurons that are connected in circuits. A fundamental bottleneck to progress is that currently available tools which propagate from neuron to connected neuron rely on neurotropic viruses which suffer from major drawbacks such as non-specific spread and toxicity. Our goal is to pursue a high-risk high-reward strategy to move beyond neurotropic viruses, by screening deep libraries of rationally designed protein sequences in mammals in vivo to achieve tags that safely ferry their fusion partners to and from specific classes of neurons.